Mechanisms of Central Synaptic Dysfunction in SMA

Project Summary
Motor circuits control fundamental behaviors such as swallowing, breathing and locomotion. Spinal motor
neurons are the key mediators translating motor commands generated within the central nervous system to
peripheral muscle targets. Motor neurons are activated by a precisely regulated pattern of synaptic activity from
sensory neurons, local spinal interneurons and descending pathways from the brain. During early development,
synaptic activity received by motor neurons shapes their functional properties. In contrast, gene mutations that
induce perturbations in either neuronal wiring or synaptic drive received by motor neurons often result in motor
system disorders. A prominent example of this situation is spinal muscular atrophy (SMA)—an inherited
neuromuscular disease caused by ubiquitous deficiency in the survival motor neuron (SMN) protein. SMA
pathogenesis involves alterations of multiple components of the motor circuit leading to abnormalities in spinal
reflexes, motor neuron loss and skeletal muscle atrophy. However, the molecular, cellular and circuit
mechanisms underlying SMA remain largely elusive. Our previous work has led us in uncovering part of the
molecular mechanisms responsible for synaptic loss, implicating in part the classical complement cascade.
Imbalance of excitatory-inhibitory neurotransmission renders vulnerable motor neurons under tonic inhibition.
Importantly, SMA motor neurons die through cell-autonomous mechanisms implicating p53 pathway, Mdm2 &
Mdm4 as well as Stasimon, a downstream target of SMN. However, the molecular and cellular mechanisms
responsible for postural and locomotor deficits in SMA mice are not known. Unraveling therefore the molecular
mechanisms responsible for these two phenotypes would provide key insights into the disease mechanisms. In
Aim 1, we will study whether dysfunction of dopaminergic synapses is responsible for the postural impairments
in SMA mice. To address this, we will employ mouse genetics together with morphological and functional assays.
In Aim 2, we will investigate the role of ventral spinocerebellar tract neurons causing gait and locomotor deficits
in SMA mice. We will also use mouse genetics, viral-mediated Cre expression, combined with morphological,
physiological and behavioral assays to complete this part of the project. In Aim 3, we will probe into the molecular
mechanisms that are responsible for synaptic loss involving CD47 and SIRPα as well as potential synergy with
C1q, the initiating protein in the classical complement pathway, under ubiquitous SMN deficiency in mouse
models of the disease.

Public health relevance
Project Narrative Neuronal control of movement is extensively studied not only because it underlies fundamental human behaviors but also because neurodegenerative diseases that affect the motor system represent a significant burden for human health. We have identified abnormalities in the way neurons communicated with each other by means of abnormal removal of synaptic connections, which result in pathological situations. Additionally, we will be investigating the cellular and neuronal circuit mechanisms involved in postural and locomotor deficits since this proposal describes a multidisciplinary effort aimed to determine the molecular and cellular mechanisms that may contribute to human diseases such as spinal muscular atrophy—the leading genetic cause of death in infancy.